Oral Trehalose Therapy to Reverse Arterial Aging in Middle-Aged and Older Adults

DESCRIPTION (provided by applicant): Age is the major risk factor for cardiovascular diseases (CVD). Two key contributors to the increased risk of CVD in middle-aged and older (MA/O) adults are stiffening of the large elastic arteries and the development of vascular endothelial dysfunction, indicated by impaired nitric oxide (NO)-induced endothelium-dependent dilation (EDD). The mechanisms by which aging causes these physiological changes are incompletely understood, but are believed to involve the development of superoxide-associated oxidative stress. Thus, establishing novel strategies to reduce arterial stiffness and increase vascular endothelial function (EDD) in MA/O adults by reducing oxidative stress is a high biomedical research priority. Trehalose is a safe and naturally occurring carbohydrate with antioxidant effects that is a promising nutraceutical for intervention in the aging process. Recent preclinical findings from our lab indicate that drinking water supplemented with trehalose reduces large elastic artery stiffness, restores NO- mediated EDD, reduces arterial oxidative stress, and reverses age-associated declines in autophagy markers in the aorta of old C57/BL6 mice. However, the effect of trehalose supplementation on vascular function in MA/O adults is entirely unknown. The goal of the present application is to translate these preclinical observations to humans. A pilot study using state-of-the-art research protocols and innovative measurements to determine the efficacy of oral trehalose supplementation for reducing large elastic artery stiffness and improving vascular endothelial function in MA/O adults will be conducted. Hypothesis 1: Oral trehalose therapy will reduce large elastic artery stiffness and increase EDD in MA/O adults without clinical disease, and the improvements will be greater with a longer duration and a higher vs. lower dose. Hypothesis 2: The improvements in vascular function will be associated with evidence consistent with reduced systemic and vascular oxidative stress and may be related to increased vascular autophagic flux. Overall, the proposed research project has the potential to influence clinical practice guidelines by establishing a novel, easy to deliver, cost-effective therapy with antioxidant and autophagy-promoting properties for treating age-associated arterial dysfunction and reducing the risk of CVD with aging.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed study will assess the ability of a naturally occurring sugar to improve the function of arteries with age. Overall, the proposed research project has the long-term potential to influence clinical practice guidelines by establishing a novel, easy to deliver, cost-effective therapy for treating age-associated arterial dysfunction and reducing the risk of cardiovascular diseases. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Age is the major risk factor for cardiovascular diseases (CVD), as >90% of all deaths from CVD occur in adults >55 years of age (77). Because the number of older adults is expected to double between now and 2050 (66), the incidence of CVD and associated costs are projected to increase dramatically in the near future leading, without intervention, to a new "baby-boomer"-driven epidemic of CVD (35). Two primary contributors to the increased risk of CVD in middle-aged and older (MA/O) adults are stiffening of the large elastic arteries and the development of vascular endothelial dysfunction (45, 63), the latter as indicated by impaired nitric oxide (NO)-induced endothelium-dependent dilation (EDD) (99). The mechanisms by which aging causes these physiological changes are incompletely understood, but are believed to involve the development of superoxide- associated oxidative stress (6, 20, 95). Thus, novel strategies to reduce large elastic artery stiffness and vascular endothelial dysfunction (NO-mediated EDD) by reducing arterial oxidative stress in MA/O adults have the potential to prevent the majority of deaths from CVD and, therefore, are of high biomedical research priority. Trehalose is a safe and naturally occurring carbohydrate (75) that improves physiological function in animal models of age-related diseases (2, 76, 92) and is a promising nutraceutical for intervention in the aging process (36). Recent preclinical findings from our lab indicate that drinking water supplemented with trehalose reduces aortic pulse wave velocity (PWV), the most clinically important measure of large elastic artery stiffness (100), restores NO-mediated EDD, reduces arterial oxidative stress, and reverses age- associated declines in the expression of autophagy markers in the aorta of old C57/BL6 mice (34, 47). However, the potential for trehalose to improve vascular function in humans is unknown. In the present application, I propose to translate these preclinical findings to humans. To do so, I will perform a randomized, double-blind, placebo-controlled intervention trial to establish the efficacy of oral supplementation of trehalose for reducing large elastic artery stiffness and improving vascular endothelial dysfunction in MA/O adults. I also seek to obtain initial insight into the mechanisms by which trehalose therapy may improve vascular function through the use of innovative translational techniques that will allow me to assess: a) the effect of trehalose on vascular oxidatative stress and nitric oxide bioavailability in humans; and b) autophagic flux and superoxide production in live endothelial cells from human subjects. Hypothesis 1: Oral trehalose therapy will reduce large elastic artery stiffness and increase NO-mediated EDD in MA/O adults without clinical disease. The improvements in vascular function will be greater with increasing duration of treatment and with a higher vs. lower treatment dose. Specific Aim 1: To determine: a) aortic PWV; b) brachial artery flow-mediated dilation (FMDBA) and c) acetylcholine-induced increases in forearm blood flow ( FBFACh) in the presence/absence of NO inhibition (NO-mediated EDD) before and after 4 (non-invasive measures) and 12 (all measures) weeks of oral trehalose (50 or 100 g/350 mL water x 1/d) or placebo (double-blind, randomized) in healthy men and women aged 55-75 years. Hypothesis 2: The improvements in vascular function will be associated with evidence consistent with reduced systemic and vascular oxidative stress and may be related to increased vascular autophagic flux. Specific Aim 2: To determine: a) aortic PWV, FMDBA and FBFACh during normal vs. reduced (via ascorbic acid infusion) oxidative stress; b) circulating and/or biopsied vascular endothelial cell superoxide production, markers of oxidant damage, and oxidant and antioxidant enzyme expression; and c) endothelial cell autophagic flux. Impact on the Field. The overall plan combines: novel translational research training, a highly successful senior mentor, co-mentors providing clinical and biostatistical support/training, innovative mechanistic clinical research techniques and the support of a highly experienced laboratory and expert clinical staff at the UC-Boulder campus NIH Clinical and Translational Research Center (CTRC) to: 1. Determine the efficacy and time course of 2 doses of oral trehalose therapy for reducing large elastic artery stiffness and reversing vascular endothelial dysfunction in MA/O adults without clinical disease; 2. Provide initial insight into the mechanisms by which these treatment benefits may be conferred; 4. Establish a basis for performing a larger, more comprehensive randomized clinical trial that will extend testing of the efficacy of trehalose therapy to MA/O adults with CVD and assess the effect of trehalose on clinical CVD endpoints. Overall, my proposed research project has the long-term potential to influence clinical practice guidelines by establishing a novel, easy to deliver, cost-effective therapy with combined antioxidant and autophagy-promoting properties for treating age-associated arterial dysfunction and reducing the risk of CVD with aging.